Identifying determinants of HIV-1 responsible for the nanoscale distribution and dynamics of virus assembly

Project Summary.
Human Immunodeficiency Virus Type-1 (HIV-1) assembly mechanisms, namely the acquisition of the envelope
glycoprotein (Env) into the assembling viral lattice, remains inadequately understood. The continued innovation
of tools to interrogate these molecular and nanoscale assembly processes is beginning to disclose some of the
basic principles. This proposal aims to build upon these innovations and quantify the requirements for Env
assembly by interrogating viral and host factor determinants regulating intracellular trafficking, surface display,
virus incorporation, and cell-to-cell spread. To accomplish these aims, we will adapt current superresolution
and single-molecule tracking approaches developed by our laboratory to understand the three-dimensional
structural organization and spatiotemporal dynamics of Env throughout assembly stages and cell-to-cell
spread. Next, we will dissect the long Env cytoplasmic tail to understand which residues/regions drive Env
incorporation. Finally, we propose to identify the role of host trafficking factors in regulating the surface levels
of Env. Our preliminary data supports the feasibility of our approach by demonstrating our ability to extract
quantitative information regarding the nanoscale organization and single-molecule dynamics of Env in three-
dimensions. These collective approaches will shed new light on HIV-1 assembly and cell-to-cell virus transfer,
informing new models and approaches aimed at targeting these processes therapeutically.

Public health relevance
Project Narrative. Human Immunodeficiency Virus Type-1 (HIV-1) remains as a global health burden despite effective treatments. However, poorly understood aspects of the viral infection cycle remain, such as assembly and cell- to-cell virus spread. We propose to utilize advanced single-molecule imaging approaches to understand the process of HIV-1 assembly and cell-to-cell virus spread to inform future therapies targeting these processes.